Augmenting focused ultrasound-mediated drug delivery to brain tumors with vascular normalization

The blood-tumor barrier (BTB) hinders the delivery and penetration of systemically administered
therapeutic agents into the brain tumor microenvironment. The BTB is created by dilated and leaky microvessels
that cause regional perfusion variability and poor convective delivery gradients, often while still retaining
enhanced efflux transporter expression and tight-junction integrity. To enhance therapeutic delivery across the
BTB, we and others have deployed non-invasive, MR image-guided, transcranial pulsed focused ultrasound
(FUS), in combination with microbubbles (MBs). MBs oscillate upon exposure to FUS, exert mechanical stresses
on the microvasculature, and open the BTB for augmented payload delivery. Yet, despite the promise of this
approach, there is still room for significant improvement. Indeed, spatial perfusion variability still limits MB access,
dilated tumor vessels have diminished contact with oscillating intravascular MBs, and high interstitial tumor
pressure still limits transport when the BTB is opened. Here, we aim to overcome these obstacles to more
effective FUS+MBs-mediated drug delivery by “pre-normalizing” brain tumor microvasculature via VEGF-R2
blockade, a pharmacological approach not limited by the BTB because VEGFR2+ endothelium is in direct contact
with the bloodstream. We posit that vascular normalization will improve FUS+MB drug delivery because it
reduces interstitial tumor pressure, improves tumor perfusion and oxygenation, and reverses tumor endothelial
cell anergy that limits immune cell infiltration and function.
In this proposal, for models of both primary and metastatic brain tumors, we will develop FUS+MB based
approaches that leverage vascular normalization to improve drug delivery across the BTB. Aim 1 will be to
identify vascular normalization timing window(s) that provide optimal conditions for focused ultrasound-mediated
drug delivery to brain tumors. We will identify such optimal windows for delivery of 2 different sized MRI contrast
agents [MultiHance (~1 kDa; simulating small molecule drugs) and Gad-IgG (~150 kDa; simulating mAb
immunotherapy)]. T1 MRI mapping will be used to precisely quantify the spatiotemporal distribution of contrast
agent after FUS+MB-mediated delivery. Aim 2 will use this information and leverage vascular normalization to
augment therapeutic efficacy of focused ultrasound-mediated immunotherapy delivery to brain tumors. Here, we
will deliver promising immunotherapies (αCD47 and αPD-1) that we hypothesize may best benefit from FUS+MB
delivery in the setting of vascular normalization and may also be rapidly translated into clinical trials at our
institution. Studies will include longitudinal assessment of tumor growth by MRI, generation of Kaplan-Meier
curves for animal survival, and histological analysis of tumor response. Because vascular normalization offers
opportunities for enhanced immune cell infiltration via augmented endothelial cell adhesion molecule expression,
we will also test whether tumor control occurs through CD4 and/or CD8 T cell-dependent mechanisms.

Public health relevance
Drug delivery to brain tumors is hindered by the so-called “blood-tumor barrier”. It has been shown previously that this barrier to effective drug delivery may be overcome by injecting microbubbles into the bloodstream and then activating them with focused acoustic energy (i.e. focused ultrasound) as they pass through the tumor. In this project, we aim to further improve and refine this drug delivery approach by pre-treating brain tumors with pharmacological strategies that “normalize” tumor blood vessel structure and function so that they better synergize with focused ultrasound.